ORLISTAT IN THE TREATMENT OF OBESE SUBJECTS WITH NIDDM

This study will determine the long-term weight loss effect in obese NIDDM patients maintained on oral hypoglycemic agents treated for 52 weeks with orlistat 120 mg tid or placebo in conjunction with a hypocaloric diet and behavioral counseling.